Molecular Imaging Core

PROJECT SUMMARY
Structural changes on the order of microns can have a profound effect on visual function.
Because of this, the ability to study the eye often requires high-quality histological, molecular,
and ultrastructural data. The goal of the Molecular Imaging Core is to provide vision
researchers at The University of Iowa with access to the specialized equipment, facilities and
experienced staff necessary to collect these data.
These services and expertise will be available without charge to NEI R01-funded investigators
and new investigators whose research aligns with the mission of the NEI and IVR. They will be
available to investigators with funding from other NIH agencies as well. This will accelerate the
pace of vision research at The University of Iowa by providing access to high-quality
histological and ultrastructural data and procedures.